Pilot Project

The Pilot Project Program (PPP) is an integral component of the CTEHR, supporting the mission of the Center by providing funding for cutting edge environmental health research that promotes basic science and its translational applications. This Program will support early-stage projects with the potential to advance EHS research, and enhance the human health impact of research being conducted in the Early Life Exposures, Microbiome, Chronic Disease, Metabolism and Enabling Technologies Thematic Focus Areas of the Center. The PPP has also been designed to promote utilization of the Facility Cores and enhance COEC activities. Directors of the PPP will coordinate the distribution of Program announcements, development of grant review criteria, receipt of applications, and in concert with the Internal Advisory Committee, selection and contact of external reviewers, ranking of individual projects and final recommendations for awards to the CTEHR Director. The Specific Aims of the Pilot Project Program are: Aim 1. Support collaborative inter-institutional projects to enhance EHS research, with a focus on research relevant to the Thematic Focus Areas of the Center. Aim 2. Enhance the potential for junior investigators to obtain external funding for EHS research by providing support for acquisition of Preliminary Data for grant proposals Aim 3. Promote the development of new and innovative exploratory projects (“high-risk, high-gain”) that have the potential to attract external grant support. Aim 4. Incentivize interdisciplinary research collaborations to tackle complex environmental health research problems and to attract new members to the CTEHR. The accomplishment of proposed Aims will not only result in development of new collaborations and attract new investigators to environmental health research, but also lead to successful external funding for CETHR investigators.

Public health relevance
PROGRAM NARRATIVE - PILOT PROJECT PROGRAM (PPP) The Pilot Project Program will serve to enhance the goals of the CTEHR and the NIEHS by providing funding opportunities for exploratory research, with an emphasis on junior investigators, collaborations and "high-risk, high-gain" research. With the guidance of the Executive Committee the PPP will coordinate the complete spectrum of activities required for a grant program ranging from announcement of this research grant opportunity to a timely review and funding decision. Thus the PPP will play a major role in enhancing and expanding environmental health research and collaborations at Texas A&M and the Texas Medical Center.